University of Colorado Population Center

ADMINISTRATIVE CORE
PROJECT SUMMARY
The Administrative Core represents an important component of the University of Colorado's
Population Center (CUPC) proposal in response to RFA-HD-20-015 for the Population
Dynamics Research Infrastructure Program FY 2020 (P2C). CUPC requests renewal of
infrastructure support for the five-year project period 2020–2025. The Administrative Core is
CUPC's backbone, operating in the background to enable affiliates to focus squarely on their
population science research.
The Administrative Core is staffed by a director, program manager and grant specialist, with
additional support from a university-funded Graduate Research Assistant and an undergraduate
student supported by the Institute of Behavioral Science. Changes in the core are responsive to
CUPC's growth, most notably in the last five years with affiliates engaging in increasingly
complex, problem-driven projects. An important change is the elimination of the associate
director (AD) position, thereby yielding salary savings. In lieu of the AD, the Development Core
has been restructured with five faculty leads for primary research areas as well as a speaker
series faculty coordinator. Since these new positions will also be on CUPC's Executive
Committee, these changes will increase faculty engagement with the Center and broaden
faculty participation in governance.
Combined with these salary savings, generous new university investments in CUPC provide the
opportunity to employ a full-time manager, a necessity given the additional activities taking
place in the Development Core – which is supported by the Administrative Core. New activities
include a grant writing workshop, PRA working groups, additional speakers, and additional mini-
conferences and workshops.
The other P2C-supported Administrative Core staff member will be CUPC's grant specialist who
provides personalized support with an emphasis on funding agencies and programs of particular
relevance to population research. This specialized grant support has been deemed essential
since CUPC's inception in 2005 and has provided important value-added.
Finally, CUPC benefits substantially from being embedded in IBS which has a deep pool of
efficiently-administered resources. Such efficiencies include CUPC's ability to benefit from IBS's
faculty lines, space, and administrative resources such as post-award support.